Unraveling a parabrachial circuit for the state-dependent control of rapid breathing

PROJECT SUMMARY
Breathing, unlike most motor behaviors, is under automatic control to ensure homeostasis is maintained. This
vital physiological regulation of respiratory activity has been the predominant focus of the control of breathing
field. However, in awake animals, breathing is also conditionally modified by changes in behavior and emotion,
making it highly dynamic. How these state-dependent control mechanisms allow breathing to conditionally
dissociate from its underlying physiological regulation remains far less well understood. In mice, this distinction
between automatic and state-dependent respiratory control is exemplified by the rapid breathing frequencies
that are unique to the awake state. Thus, transgenic mouse lines that allow cell-type-specific manipulations are
an excellent model system to unravel the neural circuits and mechanisms that integrate breathing with
behavior and emotion. The parabrachial nucleus of the dorsal pons is an integrative hub for many affective
states and behaviors, including breathing, and its constituent neurons are similarly diverse in their gene
expression and axonal projections. This project characterizes a novel neural circuit in the lateral parabrachial
nucleus (PBL) that exerts potent respiratory control specifically in the awake state and can drive rapid
breathing frequencies not achievable by known mechanisms of respiratory rhythm generation. By combining
modern intersectional transgenic, viral vector, and optogenetic tools, the proposed experiments explore how
and when this PBL circuit controls rapid breathing (Aim 1); identify the brain regions downstream of these
neurons that mediate their potent respiratory effects and state-dependence (Aim 2); and test whether the
canonical medullary site for respiratory rhythm generation, the preBӧtzinger Complex, is also critical for
generating the rapid and dynamic breathing patterns that characterize the awake state (Aim 3). These three
interactive Aims will provide a comprehensive understanding of the network- and cellular-level mechanisms
that mediate the unprecedented state-dependent respiratory control by this PBL circuit. More generally, this
project will establish a framework for understanding the conditional control of breathing and significantly
expand our basic scientific understanding of how breathing is integrated with behavior and emotion. Insights
from these studies may also have significant implications for understanding pathologies associated with
dysregulated rapid breathing such as hyperventilation syndrome and panic disorders.

Public health relevance
PROJECT NARRATIVE Breathing is controlled automatically to preserve homeostasis but must also be conditionally regulated to adjust breathing to changes in behavior and emotion that typify the awake state. This project characterizes a novel neural circuit in the pons important for the state-dependent control of breathing at frequencies not achievable by known mechanisms of respiratory rhythm generation. Insights gained from these studies will significantly expand our basic scientific understanding of respiratory control with potential implications for pathologies that involve links between breathing and emotions such as panic disorders.